Host Regulation of Flavivirus Infection

PROJECT SUMMARY
Viruses of the family Flaviviridae, including dengue virus (DENV), Zika virus (ZIKV) and
West Nile virus (WNV), are important pathogens with regard to human health across the globe.
These flaviviruses, which are transmitted by mosquito vectors, either usurp or antagonize a
myriad of host cell factors for their optimal replication in the human host. Whereas most efforts
in the field have focused on characterizing flaviviral interactions with components of innate and
adaptive immunity, little is still known about how host factors regulate key enzymatic activities of
flaviviral proteins. Specifically, how the activity of NS3, which is an essential viral enzyme that
encodes both a protease and a helicase, is regulated by host factors remains elusive.
The proposed study builds on a recent discovery by the Gack laboratory that showed
that dynamic acetylation of ZIKV NS3’s helicase domain critically regulates its RNA binding and
unwinding activities, and thereby is crucial for ZIKV replication. An unbiased RNAi screen
targeting all human acetyltransferases, combined with molecular and biochemical studies,
identified that an as-of-yet uncharacterized isoform of the acetyltransferase KAT5 (KAT5γ) is
responsible for NS3 acetylation. Cell biological and virological studies showed that KAT5γ
translocates from the nucleus to viral replication complexes (RCs) at the endoplasmic reticulum,
where it binds to and acetylates NS3, facilitating ZIKV replication. Importantly, our preliminary
data indicated that NS3 acetylation by KAT5γ, as well as its proviral role, are also conserved for
WNV and DENV.
Molecular, biochemical, and cell biological approaches combined with gene-targeting
screens will focus on defining in precise detail how acetylation/deacetylation regulates the
enzymatic activities of flavivirus NS3. This study will also give detailed insight into the
mechanisms by which flavivirus infection induces the relocalization of KAT5γ from the nucleus to
viral RCs, and will define the molecular determinants of KAT5γ’s binding to NS3. Moreover, we
will determine the physiological relevance of NS3 acetylation by KAT5γ for effective virus
replication and flavivirus-associated pathology.
Our studies will provide a molecular understanding of how the host acetylation
machinery controls flaviviral helicase function and thereby flavivirus replication, which may
provide the foundation for new, potentially broadly effective therapeutic approaches.

Public health relevance
PROJECT NARRATIVE The mosquito-transmitted flaviviruses dengue virus, Zika virus, and West Nile virus create significant morbidity and mortality throughout the world, therefore representing a major public health threat. In this grant, we will determine how the host cellular acetylation machinery facilitates the replication of these viruses by directly regulating essential enzymatic functions of the flavivirus NS3 protein. Insights gained from our studies may spur the design of new therapeutic intervention approaches for flavivirus-associated diseases.